Cell & Molecular Imaging Shared Resource

CELL & MOLECULAR IMAGING (CMI) SHARED RESOURCE: SUMMARY
The Aims of the Cell & Molecular Imaging (CMI) Shared Resource are to: 1) provide HCC members with
technologies, expertise, and training for state-of-the-art confocal, multiphoton, and super-resolution
microscopy, including image processing and analysis; 2) develop novel imaging methods and applications to
meet emerging scientific needs; and 3) educate, train, and consult on cutting-edge technologies. Microscope
systems available in CMI include: a Zeiss LSM 880 NLO multiphoton/confocal/Airyscan, Olympus Fluoview
FV1200 intravital multiphoton, Zeiss LSM 510 confocal, Olympus Fluoview FV 10i confocal, BD BioSciences
CARV II spinning disk confocal, and Cytation 5 Cell Imaging Multi-Mode Imager. Microscopes are equipped
with environmental chambers for temperature and CO2/O2 control to allow non-destructive high-resolution 3D
imaging of living cells and organisms. Applications include: 1) live cell imaging of parameter-sensitive
fluorophores to monitor ions, electrical potentials, radical generation, cell viability (apoptosis and necrosis), and
fluorescent protein labeling; 2) imaging of tissue sections for immunocytochemistry and fluorescent protein
distribution; 3) fluorescence resonance energy transfer (FRET) and Duolink to quantify intermolecular
interactions; 4) intravital microscopy to monitor microcirculation, leukocyte margination, mitochondrial
polarization, and other factors in living animals; and 5) automated microplate microscopy for high-content
screening of compound libraries. Imaging workstations run Imaris, Huygens, ImageJ FIJI, and other software
for image processing and analysis. Ancillary equipment includes culture hoods, incubators, and fluorescence
and absorbance plate readers. CMI services include consultation and hands-on training and assistance to
students, postdoctoral fellows, technical personnel, and both junior and senior investigators. CMI also
organizes seminars, invites leading microscope manufacturers for instrument demos, and presents a biennial
Charleston Workshop on Light Microscopy for The Biosciences that provides a solid introduction to the
concepts and practical applications of light microscopy relevant to modern cell and molecular biology, which
will next be held June 11-16, 2022. In the current cycle, CMI supported research in 59 HCC member labs,
leading to 114 publications. Under the leadership of John J. Lemasters, MD, PhD (DCT), a national leader in
mitochondria and energetics biology, CMI has grown to become a superb scientific resource for the
visualization and quantification of cellular processes. The future goals of CMI are to continue providing
outstanding services to HCC members and to expand CMI’s super-resolution and image analysis and
processing capabilities to ensure that HCC members can perform top-level research.